Determining the role of antibody epitope specificity in regulating Fc effector functions

Proposal Summary/Abstract
Antibody (Ab) Fc-mediated effector functions are an important correlate of protection against viral pathogens
such as SARS-2. Methods such as systems serology are used to evaluate what kind of effector responses are
protective for Abs against SARS-2 and other viruses, though crucial information about the epitope specificity
those protective Abs are targeting is missing. To develop the most effective variant-proof or broad vaccines
against sarbecoviruses, it is essential to determine which epitope specificities, when combined with Fc effector
responses, can offer the most broad and robust protection.
In this proposal, I aim to integrate deep mutational scanning (DMS) into systems serology, offering an
innovative approach to map the epitope specificities within distinct IgG subclass and FcγR binding compartments
of serum obtained from animals immunized with RBD-based protein nanoparticles and SARS-2 mRNA-Spike
vaccines. This integration will facilitate the correlation between the binding epitopes of Fab regions in polyclonal
Abs and the resulting Fc mediated functional responses. Although it is typically assumed there is no connection
between the epitope specificity and the Fc subclass, preliminary findings surprisingly indicate variations in
epitope specificity across different subclass compartments within the serum response, implying potential
functional implications. The proposal will further involve the profiling of Ab-secreting cells at the single cell level
to explore antigen specificity, IgG subclass, and FcγR binding properties, enabling the isolation and
characterization of monoclonal antibodies (mAbs) with diverse antigen breadth and Fc characteristics. This
multifaceted analysis will unveil patterns in epitope specificity and Fc properties at the monoclonal level. Finally,
the project will assess the protective efficacy of serum and mAbs with distinct epitope specificity/Fc properties
against homologous and heterologous SARS-2 infections, shedding light on the influence of epitope-specific Fab
binding on Fc-mediated protection.
Altogether, this proposal will make it possible to design immunization strategies that can more precisely
modulate both Ab targeting and functional responses elicited, which will allow for a new generation of broadly
protective vaccines. The mentoring phase of my proposal will take place in the lab of Dr. Pamela Bjorkman at
Caltech. I will be advised by and collaborate with Dr. Jesse Bloom for DMS, Dr. Galit Alter for systems serology,
and Dr. Mike Diamond for protection studies, gaining additional training required for this proposal. The research
and mentorship proposed here will support me in reaching my overall career goal to establish my own academic
research lab, with a focus on understanding the basic immunology of Abs targeting of viruses and designing
better viral vaccines and therapeutics.

Public health relevance
Project Narrative There have been three coronavirus spillovers in the past 20 years, the latest being COVID-19, which killed millions and caused widespread economic and social devastation. Both neutralizing antibody responses and Fc- mediated responses of binding antibodies correlate with protection conferred by COVID-19 vaccines; thus, developing an effective variant-proof COVID-19 vaccine or a broadly protective vaccine against a future zoonotic spillover will require knowing which antibody epitope specificities when combined with Fc effector responses offers the most broad and robust protection. We propose to systematically investigate the epitope specificities of different antibody IgG subclasses, or Fc receptor binding within serum from animals immunized with sarbecovirus-based vaccines and determine the functional relevance for distinct IgG subclass/epitope pairs.